Shared Resource Management

Program Director/Principal Investigator (Last, First, Middle): Chu, Edward
SHARED RESOURCE MANAGEMENT - PROJECT SUMMARY/ABSTRACT
The Montefiore Einstein Cancer Center (MECC) Shared Resources (SRs) support the entire range of cancer-
focused basic, clinical, translational, and population sciences and provide access to MECC members to state-
of-the-art methodology and instrumentation, high-level expertise and instruction, and cost-effective sources of
research support. MECC SRs are closely aligned with the scientific strategic priorities of the MECC. They greatly
facilitate research investigating cancer biology at the molecular, cellular and organismic level, including the
biology and signaling that are directly relevant to the unique Bronx patient population served by MECC;
development and evaluation of new cancer therapeutics; and identification of genetic, epidemiological,
behavioral, and social determinants of health causality in our diverse catchment area population. Additional SRs
promote the acquisition, storage, and analysis of patient sample and the management and coordination of clinical
trials within the MECC catchment area for ongoing cancer-focused research. MECC SRs are managed at
multiple levels to ensure a high quality of services, responsiveness to MECC members, and alignment with the
MECC Strategic Plan. Management tools and strategies include input to the SR directors from expert User
Advisory Committees and survey data from MECC membership; monitoring of SR performance by the Shared
Resource Oversight Committee (SROC), which is chaired by the Associate Director for SR; monthly Research
Leadership Council (RLC) meetings with all MECC SR Directors and Program Leaders; meetings with the
Excellence in Career Enrichment Leadership (ExCEL) Committee, composed of junior and mid-level faculty
members; and direct reporting by the Associate Director for SR to the Senior Leadership Team of the MECC.
MECC SRs are managed in partnership with the Albert Einstein College of Medicine (Einstein) such that MECC
contributions are used to leverage substantial institutional support. As such, oversight of SR finances is
conducted on a quarterly basis by the Associate Director for SR and the Deputy Director for Administration, in
collaboration with senior administrative officials from the Dean’s office. Leveraging Einstein support has greatly
facilitated the expansion of SR services and acquisition of innovative new instrumentation in multiple SRs.
Moreover, these quarterly meetings with the Dean’s office ensure that MECC priorities are recognized. Our active
engagement with MECC membership through user surveys, User Advisory Committees, Research Leadership
Council, and ExCEL Committee provide critical guidance in shaping new initiatives within our MECC SR
program. Future initiatives focus on developing and implementing innovative new technologies, services, and
expansion of critical SR personnel; enhancing coordination between MECC SRs; expanding education and
training initiatives; and expanding administrative infrastructure and support.
OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Chu, Edward SHARED RESOURCE MANAGEMENT - PROJECT NARRATIVE Per PAR-21-321, a Project Narrative is not required for this Component. OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page